Development of a novel NPY-sensitive microelectrode to detect endogenous NPY release

The main objective of this proposal is to develop an NPY-sensitive microelectrode for continuous
measurement of NPY using an aptamer-modified platinum microelectrode with a total size of less than 25 µm.
This will allow the research community to monitor endogenous NPY release in the intricate microenvironment
of brain slices and single cells. In this way, we can establish connections between NPY levels and neurological
disorders. To accomplish this, we propose a strategy for enhancing the detection of NPY by our previously
developed NPY biosensor. Our initial findings indicate that our NPY-sensitive microelectrode can measure
NPY with a sub-second time resolution, collecting 500 data points using intermittent pulse amperometry (IPA).
By utilizing the temporal precision offered by IPA and distinguishing non-faradaic currents and the decay of
faradaic electrical currents, our objective is to optimize the analytical signal of NPY measurements to improve
sensitivity and selectivity at the same temporal resolution of 500 data points per second.
As part of our efforts to understand the biological role of NPY, single-cell measurements will be performed
to detect the endogenous release of NPY and comprehend its effects at a cellular level. Until now,
measurements have not been possible, and given the significant importance of NPY release in neuronal
functions, we present our NPY-sensitive microelectrodes as a tool to improve our understanding of the NPY
effects in biological systems. Based on our preliminary work, our NPY biosensor has the ability to measure
dynamic NPY concentrations as low as 2 pg/mL. To achieve better biosensor performance and understand the
parameters that affect it, it is crucial to conduct thorough testing on several NPY-releasing cell lines that
provide fast NPY release. This will be accompanied by iterative optimization of procedures and data
processing. In addition, we intend to perform a comparative analysis of the optimized NPY biosensor
compared to our existing NPY biosensor.
At the same time, we will continue improving on our endogenous NPY measurements to detect NPY
released endogenously in acute hippocampal slices using the proposed electrochemical approach, which has
not been done before. We will compare the release of endogenous NPY by activating NPY cells via
optogenetics or electrical stimulation with a physiological activity pattern. This comparison will be done in slices
from mice with different levels of NPY expression and across several hippocampus pathways. The NPY
biosensor microelectrodes created in this research are seen as an essential instrument that connects the NPY
release, circuit function, and behavior. These techniques can be applied to different neuropeptides, offering a
promising opportunity for a new age in measuring the dynamics of neuropeptide brain chemistry.

Public health relevance
Neuropeptide Y (NPY) is a potent molecule that reduces anxiety and is released in the hippocampus. It has an impact on several behaviors associated with stress illnesses, such as Post-Traumatic Stress Disorder (PTSD). Currently, there is no analytical method capable of measuring neuropeptides in the brain with a temporal resolution of less than one second due to insufficient understanding of the chemical conditions present in the CA1 area during the production of NPY. This proposal aims to enhance the speed and sensitivity of the NPY-sensitive biosensor currently under development. Additionally, a technique will be established and optimized to measure endogenous NPY in single cells and brain slices. By directly measuring NPY, we can better understand the correlation between NPY and neurological diseases.